Optimizing Response to Chronic Pain Treatments in Veterans: Identifying Key Moderators

Contact PD/PI: Jensen, Mark Philip
Project Summary
Chronic pain is a prevalent, disabling problem affecting as many as 50% of men and 75% of women Veterans.
The psychosocial pain treatment with the most empirical support is cognitive behavior therapy (CBT).
However, not everyone benefits from CBT. Prior research has shown that two complementary and integrative
health (CIH) interventions, Mindfulness-Based Cognitive Therapy (MBCT) and Hypnotic Cognitive Therapy
(HYP-CT), are beneficial and offer alternatives to CBT and have similar efficacy. As with CBT, individual
response to these treatments also varies considerably. Our preliminary data suggests the variability in
treatment outcome may be due to important baseline patient differences. This suggests the possibility that
patients can be effectively “matched” to the treatments they are most likely to benefit from, based on
information that can be obtained before treatment starts. Research is needed to develop patient-treatment
matching algorithms that could match a given individual to the evidence-based treatment most likely to be
beneficial given their unique individual profile. The overall aim of the proposed study is to address this need by
identifying patient factors that determine who benefits most from two CIH treatments and the current gold
standard non-pharmacological treatment (CBT), relative to usual care. This aim will be addressed using a
clinical trial in which participants will be randomized to one of the four treatment conditions. We will test
hypotheses – developed from both theory and prior pilot research – that pre-treatment brain activity patterns,
hypnotizability, catastrophizing, and mindfulness moderate pre- to post-treatment improvements in pain
intensity associated with group-delivered CBT, MBCT, and HYP-CT, relative to usual care, in Veterans with
chronic pain. The findings will provide the foundation for building an algorithm to support personalized care,
whereby Veterans can be offered the treatment that will be most beneficial for them. This study will also help
develop knowledge about potentially powerful alternatives to pharmacological analgesic approaches. Finally,
the study findings will be useful to health care providers and their patients to facilitate shared decision-making.
Project Summary/Abstract Page 8

Public health relevance
Contact PD/PI: Jensen, Mark Philip Project Narrative While behavioral treatments for chronic pain are effective on average, some people benefit greatly from treatment while others benefit very little, and the same person may respond much more to one type of treatment than another. This project aims to better understand the patient factors that could be used to identify – before treatment –who will benefit the most from each of three different chronic pain treatments: cognitive behavioral therapy, Hypnotic Cognitive Therapy, and Mindfulness-Based Cognitive Therapy. The knowledge gained from this research will provide an essential platform for developing algorithms to effectively match patients with chronic pain to treatments that are most likely to be benficial for them. Project Narrative Page 9